SAFETY AN EFFICACY OF ULTRADOL/INDOCIN IN DEGENERATIVE JOINT DISEASE

The purpose of this study will be to evaluate the efficacy and tolerability of Ultradol when compared with Indocin with special attention to renal function as well as non-steroidal anti- inflammatory efficacy in patients with symptomatic degenerative joint disease of the hip and/or knee with known response to non- steroidal, anti-inflammatory drug therapy.